Delineating how epigenetic regulation of ACVR1C contributes to age and AD-related memory impairments in females and males

PROJECT SUMMARY (See instructions):
15-20% of the US population 65+ is predicted to be cognitively impaired. Age serves as the strongest risk factor for
Alzheimer's Disease (AD) with 38% of cognitively impaired older adults predicted to develop AD within 5 years.
Therefore, our ability to understand and identify mechanisms underlying age and AD-related cognitive decline that
inform discovery of effective treatments for improving cognitive function is of utmost importance. The long-term goal of
this research proposal is determine whether ACVR1 C functions as a self-regulating mechanism underlying age and ADrelated
impairments in cognitive function where, downstream regulation becomes impaired with age and AD, and is
maintained through self-directed aberrant epigenetic transcriptional repression in the female and male brain. The
proposed experiments will test the central hypothesis that ACVR1 C represents a key novel mechanism that is disrupted
with age and AD and contributes to age and AD-related cognitive decline.
In the K99 phase of this award, I found that a member of the TGFr.. signaling family Acvr1c, serves as a bidirectional
regulator of long-lasting forms of synaptic plasticity and long-term memory which becomes impaired with increasing age
and in AD. Overriding this impairment through overexpression of Acvr1c in the dorsal hippocampus ameliorates
impairments in long term memory and synaptic plasticity identified in aging and 5xFAD mice
In the ROD phase, I will continue to investigate the role of Acvr1c in age and AD-related memory function. I will determine
whether ACVR1 C functions as a self-regulating epigenetic mechanism mediating gene expression and memory in the
adult, aging and AD female and male brain. To better understand how downstream ACVR1 C signaling may be
contributing to impairments in age and AD-related memory formation we will first characterize how SMAD2
(phosphorylated by ACVR1C and forms a complex with SMAD4 to regulate gene expression) changes after learning in
the adult, aging, and AD brain. We will determine whether enhancing ACVR1C function rectifies impairments in
downstream SMAD signaling that occurs with aging and AD. Next, I will characterize epigenetic regulation of Acvr1c
and the impact of enhancing Acvr1c function. I will identify how ACVR1C regulates gene expression and chromatin
accessibility by performing snRNA-Seq and snATAC Seq following viral manipulations which enhance or repress Acvr1c
function. These findings will 1) identify ACVR1 C as a novel self-regulating mechanism responsible for maintaining
epigenetic dysfunction and repression associated with aging and AD-related cognitive dysfunction and 2) identify novel
gene targets regulated by this mechanism which provide insight for therapeutic intervention.

Public health relevance
RELEVANCE (See instructions): Alzheimer's disease (AD) is projected to affect 7.1 million Americans over the age of 65 by 2025, a 22% increase from 2020 and age serves as the strongest risk factor with 38% of cognitively impaired older adults predicted to develop AD within 5 years. With the US population consisting of 16% of adults over 65 and a steady increase in life expectancy, our ability to understand and identify novel mechanisms underlying age and AD-related cognitive decline that inform discovery of effective treatments for improving cognitive function is of utmost importance. This proposal has the potential to uncover novel therapeutic avenues by defining how a key type 1 receptor for the TGFl3 family of signaling molecules, Acvr1c, functions with regard to normal memory processes, and becomes epigenetically altered with aging and AD in the female and male brain.